Urologic Management to Preserve Initial Renal Function Protocol for Young Children with Spina Bifida (UMPIRE)

Project summary/Abstract
Spina bifida is a major congenital anomaly of the spinal cord and the associated vertebrae. About 1645
infants are born each year in the United States with this anomaly. This spinal cord lesion has numerous
deleterious effects on the neurologic, orthopedic and urologic systems. Urological evaluation of infants
with spina bifida begins at birth. In order to understand the most appropriate way to better understand
the optimal urologic management of infants with spina bifida was to institute a multi-institutional trial
utilizing a “best practices” approach. This trial, The Urologic Management to Preserve Initial Renal
Function Protocol for young Children with Spina Bifida” (UMPIRE protocol) is now in its fifth year. The
purpose of this project in the next 5 years of patient enrollment will be to correlate data with specific
clinical outcomes including renal function, renal scarring, upper tract deterioration, bladder dynamics,
UTI’s, continence, and need for surgical intervention. These findings will allow one to then better define
changes that need to be made to the best practices protocol to better achieve the optimal urologic
management of these individuals.

Public health relevance
Project narrative The purpose of this project is to implement and evaluate an already developed best practice urological protocol. The Urologic Management to Preserve Initial Renal Function Protocol for Young Children with Spina Bifida (UMPIRE protocol) will be utilized by 9 spina bifida clinics across the U.S. The goal will be to better define changes that need to be made to the best practices protocol in order to better achieve the optimal urologic management of these individuals.